Biostatistics Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
BIOSTATISTICS SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The increasing variety and complexity of data types, analytic approaches and study designs utilized in cancer
research necessitate the availability of an organized and centralized biostatistics resource that can offer a wide
range of statistical expertise, collaboration, and training opportunities to investigators at the Montefiore Einstein
Cancer Center (MECC). The Biostatistics Shared Resource (BSR) is staffed by experienced statisticians with
strong track records in effective collaboration across all scientific programs, innovative research in cancer
relevant statistical areas, and in training and mentoring investigators at all levels. BSR personnel have critical
roles in enhancing the Center infrastructure and fostering multi-disciplinary team science given their broad
knowledge of the scope of research activities within the MECC and active involvement on various cancer center
committees. The specific objectives of the BSR are: (i) To provide state-of-the-art biostatistical and bioinformatic
support on all phases of cancer research, from experimental design and study conduct to data analysis and
manuscript preparation; (ii) To collaborate on the development of methodologically rigorous grant applications
and new research initiatives; (iii) To assist with the development and scientific review of clinical trial protocols;
(iv) To develop innovative biostatistics and bioinformatics approaches to address analytical challenges from new
technologies in cancer research; (v) To offer a wide range of biostatistics training opportunities to MECC
members and to mentor junior cancer investigators; (vi) To enhance the MECC infrastructure and foster
interdisciplinary collaborations via participation on scientific and administrative committees and interactions with
other shared resources.
In the next funding period, to be in line with the strategic research priorities of the MECC, the BSR will focus on
strengthening methodological expertise to address the anticipated needs of existing and newly recruited MECC
researchers. Specifically, we have recently established the Subcore of Clinical Trials Methodology focusing on
novel clinical trials and pragmatic trials on cancer screening and therapy. In addition, we aim to increase
expertise in machine learning approaches that can integrate clinical, laboratory, and different types of high
dimensional omics data on cancer etiology, prognosis and precision medicine and prevention and to increase
research to address health disparities.
The overall goal in accomplishing these objectives is to provide a robust, comprehensive and cost-effective
system of statistical support for MECC investigators that contributes significantly to advancing the understanding
of cancer etiologies and prognosis, as well as improving cancer prevention, detection and treatment strategies.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward BIOSTATISTICS SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page